Behavior Core

The Behavior Core is built on a strong foundation of expertise in the fields of rodent sensory testing, pharmacological and
optogenetic manipulation of neurons, preclinical early-stage drug discovery and development, and genotyping and colony
management. The BC has become a critical resource for both COBRE and non-COBRE-affiliated investigators at the
University of New England (UNE), regional and national academic users, and industry partners. Across Phase 3, the Core
will continue to build on this diverse user base to create a stable and reliable revenue stream with the goal of becoming a
sustainable resource for users requiring high quality in vivo testing. The BC will continue to provide (a) a centralized
space for many behavioral assays and surgical procedures; (b) standardized protocols and training between laboratories to
reduce variability and increase reproducibility and validity of behavioral assays; (c) advanced training and model
development and validation (e.g., alternatives to reflexive nociceptive responses such as affective, cognitive, and pain-
suppressed readouts). New developments include expanded space and equipment for independent testing areas for rats and
mice to increase throughput and diminish potential confounds of testing both species in the same areas, expanded
breeding and genotyping services to support the increased utilization of genetically-modified mouse and rat models, and
support for investigators’ utilization of optogenetic approaches in behavioral studies. Continued training of Core research
staff will be provided to ensure that the highest level of innovation and support can be provided to Behavior Core users.
User feedback from internal and external users has consistently been highly positive. Core personnel have been included
as authors on publications and Behavior Core services have been included in NIH grant submissions. Continued
investments in its capabilities will allow the Core to provide the latest experimental tools in animal research and help the
Core transition to fiscal independence. Noting the value that the COBRE research cores bring to UNE, the institution has
outlined a commitment to support the Behavior Core for at least 5 years beyond the end of the Phase 3 funding period.
Institutional commitments include dedicated laboratory space and shared costs for equipment purchase, maintenance, and
upgrades, a voucher program for Behavior Core use and training, and support of dedicated effort for Core Directors. Such
support will foster the growth and expansion of Behavior Core resources required to maintain the high-quality services
currently appreciated by current users. The Behavior Core Director has worked closely with neighboring COBRE and
INBRE supported research cores at the Maine Medical Research Institute and the Mount Desert Island Biological
Laboratory to coordinate Behavior Core services with other regional research cores. This coordination will allow the
Behavior Core to broaden its user base as it prepares for long-term sustainability.